Policy Analysis and Dissemination Core (PAD)

Policy Analysis and Dissemination Core – Abstract
The Policy Analysis and Dissemination (PAD) Core of the Center for the Assessment of Tobacco Regulations will develop well-supported research-based input policy and health effect parameters needed for the modeling conducted as part of the Center’s four projects and for rapid response requests.
Through achieving its aims, the PAD Core will 1) conduct analyses to enhance our understanding of the impacts of implementation on tobacco regulatory policy, 2) conduct evidence syntheses to provide informed estimates of the impacts of regulations and the health effects of tobacco use, and 3) serve as a hub for the translation of CAsToR's research project findings to inform the FDA CTP and the tobacco regulatory and control community in general.
By proceeding from detailed comparative case studies to evidence synthesis, detailed comparative case studies, policy surveillance, and tailored dissemination efforts, the PAD Core will provide policy-critical findings in a timely and accessible manner to a wide range of policymaking, scientific, and lay audiences.